PRECLINICAL TOXICOLOGY - SEGMENT II TERATOLOGY STUDIES O

The investigator will evaluate 4 possible cancer preventive compounds in rats and rabbits for effects on organogenesis. Rangefinding and definitive tests will be performed to evaluate soft tissue and skeletal malformations as well as maternal toxicity, litter number and sex, gross malformations and other endpoints per the UAFDA-ICH Guideline on Detection of Toxicity to Reproduction for Medicinal products. The studies will be conducted under GLP for submission to the FDA.